Center for Quantitative Biology: A focus on "omics", from organisms to single cells

Center for Quantitative Biology: A focus on "omics", from organisms to single cells
PROJECT SUMMARY
High-throughput genomic, proteomic, metabolomic, and immune-profiling technologies now provide a wealth of
data that can be mined to interrogate basic biological processes, changes in cellular or organismal populations,
and the molecular bases of disease, at levels ranging from the whole organism to single cells. The rapid
advancement of high-throughput technologies for measuring biological systems has generated a significant
demand at Dartmouth College for platforms that support ‘-omics’ in single cells, but also multidisciplinary and
interdisciplinary approaches to computational biology. The goal of this COBRE program is to establish a Center
for Quantitative Biology (CQB), which will support and enhance NIH-funded quantitative biological research at
Dartmouth and facilitate its integration with wet-bench, experimental biology. The CQB will draw upon Faculty in
the Arts & Sciences, Thayer School of Engineering, and the Geisel School of Medicine at Dartmouth. The
success of CQB will benefit the entire Dartmouth community by facilitating data integration at all levels. The
Center will recruit and provide a cohesive community for diverse scientists that could have homes in departments
spanning Geisel, Arts & Sciences and the Thayer School, including Biomedical Data Science, Molecular &
Systems Biology, Epidemiology, Microbiology and Immunology, Biological Sciences, Computer Science and
Mathematics. Through its emphasis on next-generation data, as well as analysis of wet-bench-based “big data”
omics, CQB is will synergize computational biology and biostatistics with ongoing experimental genomic
initiatives across Dartmouth. This goal is being accomplished through the following three specific aims: Aim 1:
Maintain the CQB, which will be focused on developing, supporting, and enhancing computational biology and
single-cell dynamics, be nationally and internationally recognized, and foster highly productive collaborations
among experimental biologists and quantitative researchers. The COBRE-CQB will provide a key environment
for additional faculty recruitment, mentoring, education, and research in quantitative biology. Aim 2: Expand the
breadth and impact of research from NIH-funded quantitative biologists at Dartmouth by: (1) continuing to recruit
talented quantitative biology faculty; (2) further mentoring junior quantitative biologists; and (3) provide systems
for translating single-cell dynamics to applications in human disease. Each project in the program will focus on
a different aspect of computational biology and genomic research, with the shared goal of identifying factors that
influence common human diseases, such as cancer. Aim 3: Promote synergistic collaborations between
quantitative biologists and experimental biologists through five related research projects, a Single-Cell Genomics
Core, and a Data Analytics Core. The five projects will be supported by an Administrative Core (that will provide
oversight and management for the grant). Dartmouth has also made a substantial institutional commitment to
the success and long-term sustainability of the CQB, including the commitment to hiring five new tenure-track
faculty across campus. Dartmouth will also provide institutional program enrichment funds to support research
infrastructure, scientific exchange, and a pilot project program to foster a vibrant intellectual community, recruit
new project leaders, and enhance the impact and funding competitiveness of all CQB members. With
experienced leadership, efficient administrative structures, and a compelling vision for a new paradigm that
interweaves computational and experimental early-stage translational research, CQB will develop a critical mass
of extramurally-funded investigators and thus thrive as a freestanding, nationally-recognized Center of
Biomedical Research Excellence at Dartmouth.

Public health relevance
PROJECT NARRATIVE We propose to establish a new Center for Quantitative Biology (CQB) that will first nucleate and then grow the fusion of wet-bench “-omics research” with bioinformatics at Dartmouth. We will develop and establish new projects that seek to understand changes in organisms and tissue biopsies, down to the detail of single-cell dynamics, using high-throughput methods and integration of diverse ‘-omic’ data. These approaches can be applied to diverse systems, diseases, cell types, and organisms to improve our understanding of disease and human health. The proposed COBRE Center for Quantitative Biology will provide unique resources to investigators at Dartmouth and our IDeA partners, enhancing research productivity and funding competitiveness across the region.